Presynaptic RNA binding protein regulation of learning and memory in C. elegans

PROJECT ABSTRACT
Local protein synthesis in neuronal synapses is necessary for several aspects of learning and memory,
including synaptic plasticity and consolidation of long-term memories. Studies of local protein synthesis have
long suggested that translation occurs in presynaptic areas, but presynaptic protein synthesis has only been
widely accepted by the scientific community in the last decade. As a result, virtually all studies looking at learning
and memory have focused on post-synaptic protein synthesis. However, presynaptic protein synthesis also
occurs during learning and memory across animal species, raising the question of how presynaptic protein
synthesis is regulated and how this contributes to learning and memory. Thus, our lab set out to identify
presynaptically localized transcripts and study their role in learning and memory. Subcellular sequencing of
neuronal somas and synapses in the nematode worm Caenorhabditis elegans showed that presynaptic areas
are enriched for mRNA transcripts encoding RNA binding proteins (RBPs). Studies in mammals have shown
that RBPs are upregulated in presynapses following memory training in rats, and post-synaptic RBPs are key
regulators of post-synaptic protein synthesis. Thus, RBPs may be key regulators of presynaptic protein synthesis
during learning and memory, but further investigation is needed to test if this is the case. To this end, I propose
aims to understand how presynaptic RBPs contribute to cognitive function and memory
. I will use the nematode
worm C. elegans for the proposed experiments because it is the only organism that has a well-defined
presynaptic transcriptome, advanced genetic tools, and exhibits evolutionarily conserved memory. In Aim 1, I
will test the hypothesis that loss of conserved, presynaptically enriched RBPs will modulate learning and
memory. Specifically, I will knock down presynaptically enriched RBPs and test the effect of RNAi knockdown
on positive olfactory associative memory in C. elegans. Preliminary data suggests that these tests will reveal
presynaptic RBPs as novel memory regulators. In Aim 2, I will mechanistically study how RBPs can modulate
learning and memory by identifying the mRNAs bound by a known memory-regulating RBP, PUF-8. I will then
test the functional consequences of these mRNA targets on learning and memory. In Aim 2.1, I will perform
eCLIP-seq on PUF-8 before and after memory training to identify mRNAs that are bound by PUF-8 in a memory-
dependent manner, which are likely downstream memory-regulating genes. I will then validate my eCLIP findings
by ensuring that these mRNA targets co-localize with PUF-8 in presynapses (Aim 2.2) and have functional
consequences on learning and memory (Aim 2.3). Combined, the proposed studies will provide novel insight into
the role of presynaptic transcripts in learning and memory. More specifically, because RBPs are understudied in
terms of presynaptic translation, this proposal will address the mechanism of RBP control of downstream mRNAs
during learning and memory.

Public health relevance
PROJECT NARRATIVE This proposal explores a novel mechanism of presynaptic RNA binding proteins controlling target mRNAs to regulate learning and memory. Furthermore, because RNA binding protein dysfunction is known to play an important role in many neurological disorders such as Fragile X Syndrome, Autism, and Alzheimer’s, my studies may also give new insight into the role that RNA binding proteins play in neurological disease. Illuminating the importance of 1) presynaptic transcripts in learning and memory and 2) RNA binding proteins as memory regulators may reveal pathways suitable for pharmacological manipulation to treat diseases that cause cognitive dysfunction.